Understanding functions of LTR retrotransposon activation in preimplantation development

Understanding the functions of LTR retrotransposon activation in preimplantation development
Abstract
Accumulating evidence indicates that retrotransposons, especially long terminal repeats (LTRs), can act as cis-
regulatory elements, such as promoters and enhancers, to regulate host gene expression. After fertilization, the
mammalian zygote activates its own genome in a process called zygotic gene activation (ZGA). Hundreds of
retrotransposon subfamilies—which are repetitive elements that constitute ~40% of our genomes—become
activated as well. This wave of retrotransposon activation is considered critical for ZGA and early embryogenesis,
with its disruption leading to embryonic arrest. Similarly, in human in vitro fertilization, ~40% of embryos arrest
during ZGA, and this is associated with mis-expression of retrotransposons. Thus, understanding the functions
of retrotransposon activation during ZGA has important implications for both basic biology and reproductive
medicine, but how specific retrotransposon subfamilies and single copies regulate ZGA, and preimplantation
development is not known. The overall goal of this proposal is to understand to what extent LTR retrotransposon
activation regulates ZGA and early embryogenesis. Genetic manipulation of retrotransposons is technically
challenging because each retrotransposon subfamily has hundreds to thousands of copies interspersed
throughout the mouse genome. Indeed, only a single LTR-derived promoter has been characterized in mouse
preimplantation embryos. To overcome this barrier to progress, our lab recently developed a CRISPR
interference (CRISPRi) method in mouse embryos that can systematically evaluate cis-regulatory functions of
retrotransposons at the entire subfamily level (i.e., thousands of copies simultaneously). Using this method, we
determined cis-regulatory activities of ~3500 copies of the MT2 subfamily, a ZGA and totipotency marker, at the
2-cell stage (when ZGA occurs). By integrating functional perturbation and multi-omics analyses, we identified
hundreds of MT2 copies that function as promoters and/or enhancers during ZGA. Building upon this work, we
aim to identify MT2-derived promoters and enhancers that are important for ZGA and preimplantation
development and systematically evaluate to what extent ZGA depends on LTR retrotransposon activation. These
goals will be achieved through integrative approaches such as epigenetic editing and base editing in zygotes,
genetically engineered mouse models, and ultra-sensitive epigenome profiling. Completion of the proposed
study will identify retrotransposon subfamilies and single copies that are important for early embryogenesis and
provide novel insights on ZGA regulation in preimplantation embryos. Our findings will set the stage for
understanding how retrotransposons participate in gene regulation in human embryogenesis. Collectively, these
studies will advance our fundamental understanding of mammalian early development, with broader implications
for improving reproductive technologies.

Public health relevance
PUBLIC HEALTH RELEVANCE Retrotransposons are transposable elements that constitute ~40% of human genomes, and their activation is essential for embryonic development. In human in vitro fertilization, ~40% of embryos arrest early, which has been associated with mis-expression of retrotransposons. The goal of this proposal is to understand how retrotransposon activation regulates mouse early embryonic development, and discoveries made from this work may aid to develop strategies to improve reproductive technologies.